Determinants of H. influenzae Virulence in Otitis Media

PROJECT SUMMARY
Despite the relative success of pneumococcal conjugate vaccines (PCVs) against pneumococcal otitis media
(OM), the incidence of all-cause OM remains unacceptably high worldwide and broad use of PCVs has also
changed the microbiology of OM to one in which nontypeable Haemophilus influenzae (NTHI) predominates.
Additionally, whereas the importance of biofilms in OM pathogenesis, chronicity and recurrence is recognized,
and the recalcitrance of biofilms to antimicrobials is well accepted, we nonetheless still treat OM with oral
antibiotics that do not reach levels in the middle ear required to kill planktonic bacteria, let alone those resident
in a biofilm. The use of broad-spectrum antibiotics is also not without consequence. Rashes and diarrhea are
common, and we now know that early life use of antibiotics disrupts development of the very gut microbiome
that is essential for normal human immune system development. Due to global concerns about these issues, in
a recent Nature commentary, thought leaders encouraged us to consider new ways to combine the protection
offered by effective induced antibodies with the more appropriate use of antibiotics as our “last hope against
multi-drug resistant bacteria and persistent disease”(55). With the recent recognition that bacteria which cause
persistent diseases exist in not only planktonic or biofilm-resident states, but also a third distinct newly
released (NRel) state that is the most sensitive to killing by antibiotics, we envision use of specifically targeted
antibodies to release bacteria from their highly resistant biofilms so they can now be killed by both host
immune effectors and, if necessary, traditional antibiotics but now used at a markedly reduced dose and for a
limited time. We demonstrate via many new preliminary data that NRel NTHI are highly unique and further, that
NRel NTHI populations are distinct from each other, dependent upon the specific effector that induced their
release. Here, we strive to combine our expertise in immunology with both our advanced understanding of
biofilm structural biology and our growing appreciation of the NRel NTHI state. Integration of these concepts
provides us with the opportunity to develop a truly novel approach that we believe could offer a viable option
with which to combat chronic and recurrent OM. We will utilize our understanding of both the NRel phenotype
and the activity of specifically directed antibodies to leverage their combined power. In Aim 1, we will use
established in vitro assays to determine how environmental conditions (singly and in combination) affect the
kinetics, extent of duration and phenotype of NRel bacteria as a target for intervention to identify the control
points and rate-limiting steps that confer greatest vulnerability. In Aim 2, we will further define the significant
vulnerability of the NRel state in OM through changes in release kinetics, gene expression and clearance of
otopathogenic biofilms by innate immune effectors. In Aim 3, we will conduct preclinical testing of specifically
targeted antibodies capable of inducing the NRel state to resolve experimental OM due to NTHI, the
predominant pathogen of acute OM, recurrent OM, chronic OM, CSOM and OM that fails treatment.

Public health relevance
PROJECT NARRATIVE Via our long-standing efforts to develop novel approaches for the better management and prevention of otitis media (OM), we have extensively characterized the functionality of antibodies directed against two unique biofilm-associated determinants of nontypeable Haemophilus influenzae (NTHI) that both prevent biofilm formation and, uniquely, disrupt pre-existing biofilms in vitro and in vivo. Action of these antibodies release this predominant otopathogen from its protected residence within the biofilm into a highly vulnerable ‘newly released’ (NRel) state, a recently discovered phenotype which is the most sensitive to killing by traditional antibiotics, and extends our understanding beyond the heretofore believed duality that bacteria responsible for chronic and recurrent diseases exist only in either a ‘planktonic’ or ‘biofilm-resident’ state. In consideration of a recent paradigm shift, wherein thought leaders have challenged us to consider new ways to combine the power of induced immunity with the more considered use of antibiotics as our “last hope against multi-drug resistant bacteria and persistent disease” as a means to achieve the strongest possible therapeutic outcome, herein we have designed studies that will expand upon compelling preliminary data to use specifically targeted antibodies to force recalcitrant biofilm-resident NTHI into the highly vulnerable NRel state so they can now be readily eliminated, and thereby leverage our new understanding to more effectively combat NTHI-induced OM and multiple other diseases caused by this high priority, antibiotic-resistant pathogen.